Cancer Research Training and Education Coordination

Abstract Cancer Research Training & Education Coordination (CRTEC)
The City of Hope Comprehensive Cancer Center (COHCCC) is committed to the education and training of the
next generation of staff, clinicians, and researchers beginning in grade school and continuing through
postdoctoral training. Cancer Research Training & Education Coordination (CRTEC) is directed by Joanne
MortimerCI, MD, drawing on the expertise and resources of the Education and Training Council (ETC), which
consists of 35 institutional leaders who represent training initiatives across the campus and community. The ETC
meets monthly and provides oversight for developing new educational courses, coordinating cancer-related
education across COH, fostering the career development of our trainees and faculty, evaluating the efficacy of
our educational programs, and ensuring that training in core competencies is provided. Dr. MortimerCI, together
with the ETC has established an Office of Mentorship and recruited Carlotta GlackinMCBC, PhD, to oversee
mentorship alignment across COHCCC. The institutional and CCSG leadership are dedicated to investing in
training and developing a diverse workforce; establishing an exceptional environment to facilitate and accelerate
transformative discoveries; developing and applying resources for faculty, staff, and students to ensure academic
success; and centralizing on-going training initiatives for researchers, clinicians, and staff. In the current funding
climate, newer faculty need additional training to become more independent researchers, and the COHCCC is
committed to supporting training opportunities through special seminars and workshops, as well as travel funds
for trainees to attend and present at national meetings. Over the past funding cycle, CRTEC has coordinated
programs that serve learners from all stages of training and diverse backgrounds. High school and
undergraduate students received intensive research experiences through the Eugene & Ruth Roberts Summer
Academy (established in 1960) and now supported by the TEAMS Stem Cell Biology program, and also from a
YES2SUCCESS (R25CA233431) program focusing on multidisciplinary training of students from under-
represented groups (URG). For undergraduate/graduate learners, we offer the CIRM Bridges and Stem Cell
Biology programs, the TGen Scholars Program, an existing postdoctoral training program (T32CA186895) which
focuses on DNA damage response and oncogenic and signaling, and a newly awarded T32CA221709 in Cancer
Metabolism. Early-stage investigators (ESI) are the focus of the Paul Calabresi Career Development Award for
Clinical Oncology (K12CA001727: PI J. MortimerCI), which sponsors the Clinical Investigator Training Program
(CITP) to ensure rigorous education in clinical/translational research. CITP courses are available online or in-
person to all City of Hope investigators, and many ESI and postdoctoral fellows from basic/translational labs also
participate. Four NCI-funded R25 grants continue to provide training opportunities for regional and national
physicians and allied health professionals. COHCCC has demonstrated its commitment to education and training
through the judicious use of $3.9 million in peer-reviewed funding.